Core A: Administrative Core

The purpose of CORE A is to provide administrative support to the Program Leaders, to the Principal
Investigators of the Projects and Cores, and to the scientific personnel of the Projects and Cores of the
Pathogen Response on Immunotherapy Study Group (PRIG). CORE A will be located in Dr. Chung's
laboratory/office complex at the Gastrointestinal Division of Massachusetts General Hospital. The main goals
of CORE A are to manage and oversee the scientific efforts of the Projects and to coordinate scientific and
administrative interactions. Thus, the specific tasks of CORE A will be: (a) to facilitate interactions between
Program Investigators, Scientific Advisors and administrative personnel, (b) to plan and coordinate the External
Scientific Advisory Group (ESAG) meeting as well as meetings between Program scientists, (c) to organize
and coordinate travel for scientific advisors, visiting scientists and Program Investigators, (d) to assist in the
organization of the enduring seminar series and annual External Scientific Advisory Group Meeting and
Scientific Symposium, (e) to facilitate resource sharing including assisting in the speedy execution of material
transfer agreements (MTA) and (f) to assist the Program Directors and Principal Investigators in preparation of
progress reports, financial reports and manuscripts for publication. CORE A will also be responsible for the
resolution of any potential conflicts.

Public health relevance
Infectious disease is a major cause of morbidity and mortality. The inability to perturb, and then study the effects of specific immune pathways in humans is a major limitation to developing better therapeutics against pathogens. Here we will exploit a novel immunotherapy (anti-PD-1) developed clinically for cancer, to investigate fundamental immune mechanisms in chronic HBV infection and during influenza vaccination.